Leveraging game-based mobile app to limit excessive weight gain and retention among pregnant women with overweight and obesity

PROJECT SUMMARY
Gestational weight gain (GWG) has important implications for maternal and child health and is an ideal modifiable
factor to improve short- and long-term health outcomes among women and children. Here we propose to develop
and test a game-based mobile app (GWG-DH) to prevent excessive gestational weight gain (GWG) and limit
postpartum weight retention (PPWR) among women in Nepal who enter pregnancy with overweight and obesity
(BMI≥25 kg/m2
). In the R21 phase, we will apply a user-centered agile design approach to adapt our existing app
GDM-DH (developed to support diet/lifestyle modification in Nepalese pregnant women with gestational diabetes)
and expand and refine it to make a game-based weight management app (GWG-DH) that matches the needs and
technological sophistication of our target users (Nepalese pregnant women with overweight and obesity). The R33
phase will employ a Type I Hybrid Implementation Science Framework to test the efficacy of the GWG-DH
intervention against standard care via a randomized control trial (RCT), while also evaluating its potential for
implementation in real-world settings. In Year 1, we will select content modules and features for the GWG-DH app
based on evidence review, theory-based behavioral change techniques, and expert discussions. Next, we will
conduct design workshops with 18 target users to customize the features and game elements to match user
preferences and ensure cultural relevance. Following this, we will create the app’s prototype and conduct interviews
with 5 health providers and conduct 3 rounds of focus groups with target users (n=18), asking them to view the app
prototype and provide feedback on its features, functions, and content. In Year 2, the revised GWG-DH app will
undergo usability testing (n=27), followed by the full development of the app (beta version), and 3-month Beta
testing (n=27) to assess its functionality, usability, and acceptability. With iterative refinements of the beta versions,
we will build the final ready-to-test version of the GWG-DH for evaluation in the R33 phase (Years 3-5). For the
RCT, we will recruit 360 pregnant women with pre-pregnancy BMI≥25 kg/m2 and randomly assign them into either
(A) standard care, or (B) GWG-DH app + standard care, with up to 1 year of intervention, from 16±2 gestational
weeks to 6 months postpartum. Potential mediators will be assessed at 34±3 gestational weeks and 3 months
postpartum. Primary (weight) and secondary (diet/lifestyle) outcomes will be assessed at 34±3 gestational weeks,
delivery and at 6 months postpartum. We hypothesize that compared to standard care, the use of GWG-DH app in
addition to standard care will result in a lower rate of excessive GWG, lower PPWR, better diet quality, and greater
level of physical activity during pregnancy and postpartum. Concurrent with the RCT, we will conduct a mixedmethods implementation and evaluation of the GWH-DH app, following the RE-AIM (reach, effectiveness, adoption,
implementation, maintenance) framework. Findings from this study will support the dissemination and scaling of
evidence-based GWG interventions across various settings, including low-resource areas in the U.S. and maternity
care deserts, where access to maternal health services is limited.

Public health relevance
PROJECT NARRATIVE Sustainable, scalable, and cost-effective solutions are needed to address the growing public health burden of excessive gestational weight gain (GWG) and its adverse sequelae, both globally and in low- and middle- income countries (LMICs) like Nepal. Leveraging our successful work developing and testing an mHealth lifestyle intervention for gestational diabetes [R21TW011377], here we propose to take a user-centered design approach to develop and test a game-based mobile app intervention (GWG-DH) to prevent excessive GWG and limit postpartum retention among Nepalese women who enter pregnancy with overweight and obesity. If successful, the GWG-DH intervention and insights from this study’s implementation research will be highly relevant to the broader South Asian diaspora globally and will guide the future development, testing, and implementation of mHealth GWG interventions in low-resource settings across the United States, including rural areas and maternity care deserts.